Transport transforms for biomedical data modeling, estimation, and classification

The goal of the project is to develop a new mathematical and computational
modeling framework for from biomedical data extracted from biomedical
experiments such as voltages, spectra (e.g. mass, magnetic resonance,
impedance, optical absorption, …), microscopy or radiology images, gene
expression, and many others. Scientists who are looking to understand
relationships between different molecular and cellular measurements are often
faced with questions involving deciphering differences between different cell or
organ measurements. Current approaches (e.g. feature engineering and
classification, end-to-end neural networks) are often viewed as “black boxes,”
given their lack of connection to any biological mechanistic effects. The approach
we propose builds from the “ground up” an entirely new modeling framework
build based on recently developed invertible transformation. As such, it allows for
any machine learning model to be represented in original data space, allowing for
not only increased accuracy in prediction, but also direct visualization and
interpretation. As an outcome of the previous funding period, our current
approach outperforms other mathematical modeling tools when processing
segmented signals and images by a wide margin in terms of accuracy,
computational complexity, amount of training data needed, interpretability and
robustness to out of distribution samples. In this current phase we seek to
generalize the method beyond segmented images and signals to virtually any
dataset type. We will explore proof of concept applications in cytometry,
pathology, and radiomics.

Public health relevance
The project describes a new mathematical data analysis approach, rooted on transport and related phenomena, which is aimed at greatly enhance our ability to extract meaning from diverse biomedical datasets, while augmenting the accuracy of predictions as compared to existing modeling tools such as deep learning. This period of the project focuses on generalizing our previous approach to virtually all data types in biomedical data sciences. We will explore proof of concept applications in cytometry, pathology, and radiomics.